Malarial retinopathy screening system for improved diagnosis of cerebral malaria

Summary
Cerebral malaria (CM) is a life-threatening clinical syndrome associated with malarial infection.
In 2018, malaria affected more than 213 million people in Africa alone and claimed 381,000 lives,
more than 65% of whom were African children less than 5 years old. As a consequence of the high
incidence of CM, it is often misdiagnosed for other pathologies with similar symptoms, leading
to a high false positive rate for CM, incorrect treatment, and resulting mortality or neurological
disability. The specificity of the current standard of care for clinical diagnosis of CM (physical
symptoms, coma, and malaria parasite test such as rapid diagnostic testing) is reported around
61%. Therefore, there is a significant market need for a highly specific, low-cost, and easy-to-use
test to improve CM diagnosis and save lives. Since Malarial retinopathy (MR) is greater than 95%
specific to the presence of CM, retinal screening for MR represents an effective means to assist in
and improve the specificity of CM diagnosis. Screening for MR in addition to the current standard
of care improves the specificity of CM diagnosis from 61% to 100%.
VisionQuest Biomedical has developed ASPIRE, the first fully automated MR detection software
integrated with a low-cost and portable retinal camera, a system that can be operated by
minimally trained personnel such as medical technician or nurse without the need of an
ophthalmic specialist. We have assembled a multidisciplinary team of regulatory consultants,
commercialization experts, business development specialists, and clinicians; to clinically deploy
and launch ASPIRE in our target market in Africa. This team will validate and prepare ASPIRE
for regulatory clearance as well as finalize the marketing and commercial rollout strategy.
In Phase II-B, the research team at VisionQuest Biomedical deployed a fully-functional clinical
version of ASPIRE and tested it in nine malaria clinics in Africa, which demonstrated excellent
performance and usability for detecting MR, without the need of an ophthalmic expert. In CRP,
ASPIRE will be validated for technical and clinical performance and will be brought to
commercial readiness with regulatory clearance. We will accomplish this through four specific
aims. In the first aim, the software system for MR detection will be validated to bring it under
design controls. In the second aim, we will deploy ASPIRE at 25 clinics in Africa to demonstrate
safety and efficacy as well as to promote market traction. The third aim will focus on preparing
ASPIRE for regulatory submission. In the fourth aim, we will complete African healthcare market
research for a startup market of 5 countries (Malawi, Zambia, Kenya, Uganda, Rwanda) and
finalize marketing and rollout strategy. Within one year after CRP, our goal will be to deploy
ASPIRE in more than 200 malaria clinics across 5 countries in Africa.

Public health relevance
Narrative Cerebral malaria (CM) is a life-threatening clinical syndrome associated with malarial infection, which claims hundreds of thousands of lives of African children every year. The detection of retinal biomarkers of CM, called malarial retinopathy, can improve the diagnostic accuracy of CM. This project proposes the development, clinical deployment, and commercialization of a fully automated malarial retinopathy detection system consisting of a low-cost retinal camera and automatic malarial retinopathy detection software.